AXON: Axonal biomechaniX to unveil injury mechanisms in glaucomatous Optic Neuropathy

PROJECT SUMMARY/ABSTRACT
Glaucoma, a major cause of irreversible blindness, damages the retinal ganglion cell axons that carry visual
signals to the brain. The exact mechanisms and primary sites of axonal injury remain debated, challenging
clinicians to predict disease progression. Research suggests the lamina cribrosa of the optic nerve head (ONH),
where axons exit the eye, as a key injury site, though theories also consider the neuro-retinal rim and peripapillary
retina. This complexity underscores the need for deeper insights into glaucoma's pathophysiology.
Our recent work has highlighted the critical role of biomechanics in glaucoma pathophysiology. Changes in
intraocular pressure (IOP) cause distortion of the neural tissues within the ONH. The tissue-level distortions
represent an insult to the axons with several components, including stretch, compression, bending, and torsion.
These insults, when excessive, prolonged, or combined with other risk factors may lead to axonal injury. Given
that each ONH is unique and subjected to a distinct biomechanical environment, the variability could explain why
injury sites differ among individuals. However, these phenomena have never been directly observed in vivo in
humans. Our proposal aims to leverage innovative tools from Engineering, AI, and advanced imaging (optical
coherence tomography or OCT) to make these observations possible. By monitoring patients longitudinally, we
intend to unveil which mechanical insults to axons are most likely to influence vision loss progression, identify
where these insults occur, and explore variations across glaucoma subtypes and demographics.
For this grant, we hypothesize that the deformations of individual ONH axon-bundles following an acute but
gentle IOP insult reflects axonal health and could serve as diagnostic/prognostic biomarkers for glaucoma;
further the axon-level deformations will help identify the most likely primary site of axonal injury across different
glaucoma subgroups and demographics and point to the mechanisms underlying axonal damage and vision
loss. The following three aims are proposed. Aim 1. To map the human ONH axonal paths in 3D from a single
OCT scan of the ONH. Aim 2. To leverage AI to assess whether axonal deformations could serve as diagnostic
and prognostic biomarkers for glaucoma. Aim 3. To leverage explainable AI to provide insights into axonal injury
mechanisms by identifying the types of axon-bundle deformations and their locations that putatively influence
visual field loss patterns and progression; and by assessing how age, glaucoma severity, and sub-types
influence the patterns of these insults.
Our project aims to apply Engineering and AI tools to precisely characterize, for the first time, insults at the axon-
bundle level. This initiative not only holds the potential to enhance clinical practices for diagnosing and
prognosing glaucoma but also deploys explainable AI to pinpoint potential injury sites across various glaucoma
subtypes and demographics. Such advancements could significantly refine our understanding and management
of glaucoma, ultimately paving the way for innovative therapeutic approaches tailored to individual patient needs.

Public health relevance
NARRATIVE Do the axons in our eyes suffer glaucoma damage because they are being stretched, pinched, twisted, or bent from a change in eye pressure over a long period of time? By employing advanced engineering and AI tools, our research will study the mechanics of living human axons to potentially identify the primary mechanisms and locations of injury. This project could significantly advance our understanding of glaucoma's complex mechanisms and lead to the development of diagnostic and prognostic tools that would benefit patients globally.